Novel Insights into the Mechanistic Role of Small Rho GTPase in Chronic Cardiac Fibrotic Remodeling

PROJECT DESCRIPTION/ABSTRACT
The transactivation of cardiac fibroblasts plays a dual role in the process of repairing and remodeling the
heart following myocardial infarction (MI). During the post-injury acute phase, cardiac fibroblast is activated and
highly proliferative, which plays an essential role in preventing cardiac rupture and facilitating wound healing.
However, prolonged and excessive cardiac fibrosis is detrimental to the heart. Striking a balance between the
short-term benefits and avoiding long-term negative consequences associated with cardiac fibroblast
transdifferentiation has posed a significant challenge in the research field. During the cardiac remodeling
process, nature has evolved an adaptive mechanism to limit excessive fibrosis by promoting the apoptosis of
myofibroblasts and reducing extracellular matrix (ECM) protein expression. Unfortunately, these innate signals
are often insufficient to prevent chronic fibrosis, likely due to their delayed and passive activation.
In this proposal, we hypothesize that early activation of adaptive anti-fibrotic signals may offer cardiac
protection in post-MI remodeling. To achieve this overarching goal, we performed data mining in the publicly
available scRNA-seq databases. We identified the downregulation of a small GTPase, RHOE, as a potential
adaptive anti-fibrotic signal in heart failure patients. We propose to explore the dynamic role of fibroblast RHOE
in post-MI cardiac remodeling. Comprehensive experimental approaches and multiple genetic animal models
have been established and will be applied to investigate the functional role and mechanisms underlining
RHOE-mediated chronic cardiac fibrosis.
This project is a proof-of-concept study to selectively mitigate prolonged fibrosis without interrupting the
acute wound repair after ischemia injury, shedding light on novel therapeutic strategies. We expect to achieve
two main objectives: 1) defining the functional and pathological significance of RhoE in post-MI heart and 2)
uncovering novel non-canonical mechanisms through which RhoE modulates ECM reconstitution.

Public health relevance
PROJECT NARRATIVE This project studies the role of a small GTPase in regulating chronic cardiac fibrosis post- ischemia injury, leading to a new strategy to prevent deleterious excessive fibrosis while preserving the necrotic tissue repair in post-myocardial infarction remodeling.